Replication mechanisms of human papillomaviruses (HPV)

In FY2023, we have continued to explore each stage of the HPV infectious cycle. Previously, we have used quasivirus HPV infection of keratinocytes to study early events in HPV genome infection and establishment and have used proteomics to define the chromatin modifications within HPV infectious particles. We have defined the cis elements required for persistent HPV replication and we are conducting in situ chromosome capture analysis to determine the regions where HPV genomes tether to host chromosomes. We are studying the late stage of HPV replication using high resolution microscopy to define the functional architecture of HPV replication foci and are developing cell lines to visualize the formation of these foci in real time. We have identified cellular factors that augment and restrict HPV infection.